Developing Effective Approaches to Extend Hematopoietic Healthspan by Targeting Cell-extrinsic and Cell-intrinsic Alterations at Middle Age

PROJECT SUMMARY/ABSTRACT

The process of aging causes functional decline of the hematopoietic system, including reduced capacity for
regeneration, increased risk of infections, and increased risk of certain forms of blood cancer. This is a
significant health concern due to the increasing age of our population and incidence of these age-­related
conditions. No intervention therapies currently exist to extend hematopoietic healthspan with aging, largely due
to a lack of understanding of the cellular and molecular alterations that cause functional hematopoietic decline.
Our novel approach is to identify cellular and molecular signatures of functional hematopoietic decline at its
age of onset, with the rationale that these signatures will point to early causes of decline and hence identify
prime targets for extending hematopoietic healthspan. Our preliminary data demonstrate that functional
hematopoietic decline occurs by middle age, that alterations in the bone marrow microenvironment at middle
age are necessary and sufficient to cause functional hematopoietic decline, and identify alterations in the
Insulin-­like Growth Factor 1 (IGF1) signaling pathway at middle age as a strong candidate driver of functional
hematopoietic decline. This project will use cellular and molecular biological approaches in aging mice to
characterize the hematopoietic cell-­extrinsic and cell-­intrinsic alterations in IGF signaling at middle age that
cause functional hematopoietic decline. Results of this project will identify targeted, molecular-­ and cell type-­
specific therapeutic strategies to preserve regenerative capacity and immune cell function during aging.

Public health relevance
RELEVANCE TO PUBLIC HEALTH Aging is a complex process that contributes to reduced function in tissues throughout the body, including the blood system. The impact of aging on human health is of increasing societal concern due to the worldwide increase in age of our population. As no therapies currently exist to prevent aging of the blood system, there is a vital need to understand when and how proper function of the blood system begins to fail during aging. This research will provide important information that can be used to develop precision therapies to prevent this decline in function and sustain a healthy and robust blood system during aging.